Admin Core

Abstract - ADMINISTRATIVE CORE
The Gene Expression Database for Mouse Development (GXD) program will be managed by the seasoned
leadership team that has successfully led it for over two decades (Martin Ringwald, PI; Joel E. Richardson, co-
Investigator) and by Dr. Richard Balderelli, a highly qualified new co-Investigator who has worked closely with
Drs. Richardson and Ringwald for many years. We will manage the goals and set the priorities of the GXD
program on an ongoing basis. We will responsibly organize and assign the work of the GXD staff and regularly
review outcomes and priorities. We will hold joint annual meetings of our external and internal Scientific
Advisory Boards to review accomplishments, discuss barriers, evaluate all aspects of the GXD program, and
garner input on our proposed work for the coming year as well as longer term goals.